Administrative Supplement: The Effects of Unintended Pregnancy on Maternal and Child Health

Project Abstract
The central goal of our parent project, “The Effects of Unintended Pregnancy on Child Health”
(HDR01100438), is to examine how mothers’ financial access to contraception affects children’s health. Within
the scope of Parent Aim 1, this Supplement request seeks to extend recruitment for the parent grant for five
months in order to examine how the changes to federal and state reproductive health policies that occur after
the reversal of Roe v. Wade alter the causal effect of financial access to contraception on unintended pregnancy
and maternal and child health. Extending M-CARES recruitment for five months would add an estimated 600
women and 180 children to samples recruited in the post-Roe era, thereby facilitating robust comparisons of
people enrolled before and after this massive policy change under Parent Aim 4. To date, M-CARES shows that
increasing financial access to contraception has large effects on mothers’ use of more effective contraceptives
and the incidence of abortion for low-income women. These findings suggest that financial access to
contraception prevents unplanned pregnancies and could minimize the effects of Roe’s reversal on unintended
pregnancies and maternal and child health.

Public health relevance
Project Narrative This project informs public policy and public health knowledge regarding the effects of subsidizing contraceptives on unintended pregnancies and maternal and child health in the period after Roe v. Wade’s reversal. It also provides a more comprehensive understanding of how changing funding for contraception through Title X of the Public Health Service Act could affect multiple dimensions of population health.